Investigation of brain mechanisms involved in Urgency Urinary Incontinence

PROJECT SUMMARY
Prevalent, morbid, and costly (>$20 billion/year in 2000), incontinence is a major problem, especially for older
adults, in whom the most common type is urgency urinary incontinence (UUI). Ascribed to bladder spasms,
UUI's actual causes are unknown, and therapy remains inadequate. Recent data suggest that one cause is
poor bladder control by the brain. In our recent R01 we used biofeedback (BFB) as a probe to explore this. The
exciting findings suggest that there are ≥ 2 brain (pheno)types of UUI; that they respond differently to BFB, and
via different mechanisms; and that their response can be predicted. Our proposed new study will extend this
work to examine mechanisms of drug treatments to identify potentially new targets for therapy.
Data suggest that bladder control comprises 3 cerebral circuits which maintain continence by suppressing the
voiding reflex in the midbrain. In the phenotype that responded to BFB, the mechanism involved enhancing
deactivation of the first brain circuit (medial prefrontal cortex, mPFC) which resulted in less activation of the
second circuit (which includes the midcingulate cortex). In the phenotype that was resistant to BFB, no brain
changes were seen.
Yet, BFB is used less often than drugs to treat UUI. The mechanism(s) that mediate drug response are
unknown but likely involve changes in afferent activity ascending to the brain. The proposed study would be
the first to address this critical knowledge gap. It is based not only on insights generated from our BFB study,
but also on a pilot study of the bladder relaxant fesoterodine and our working model of brain/bladder control.
Our overall aim is to use fesoterodine as a physiological probe, to improve our understanding of the brain's role
in UUI and identify new targets for therapy. Specific aims are to: (1) test whether efficacy of drug therapy varies
by brain phenotype (the two identified in our BFB study or others that this study will identify); (2) confirm that
mPFC deactivation is a key therapeutic mechanism, regardless of intervention; (3) determine if drug therapy
normalizes brain response as a non-specific reaction to therapy; and (4) use newer MRI techniques to extend
our current methods and thereby confirm or refute our model of brain/bladder control.
To address these aims, we will randomize 150 women aged ≥ 60 years to receive 12 weeks of either fesoter-
odine or placebo and then switch them to the alternate therapy for another 12 weeks. The study will enable us
to correlate the change in CNS activation/deactivation with clinical response to therapy and also to discern
whether CNS changes revert as incontinence worsens following withdrawal of therapy (on placebo) and to
identify brain predictors and mechanisms of response.
The study will provide the first data on brain mechanisms involved in UUI response to a drug. Regardless of
results, it will contribute substantially to current understanding of UUI and continence, thereby enabling scien-
tists to develop new therapies based on the revolution in neuroscience—and more hope for UUI sufferers.

Public health relevance
Project Narrative Urge urinary incontinence is a common problem in older people which vastly reduces quality of life, yet the cause and mechanism of disease are not well understood. This study will further investigate the brain mechanisms involved in continence by evaluating brain changes after treatment by an anticholinergic drug to reduce urine leakage. This will expand our current knowledge of how the brain controls the bladder, better characterize the drug action mechanism and suggest ways in which we can better target treatment.